Gene Therapy for Cystic Fibrosis Using Novel Compact Promoters

PROJECT SUMMARY/ABSTRACT
More than 30,000 people in the U.S. suffer from cystic fibrosis (CF), an autosomal recessive disease caused by
mutations in the CFTR-encoded chloride channel. At least 1,800 disease-causing mutations in CFTR have been
identified, and despite remarkable progress, the most effective pharmaceutical options do not benefit ~10% of
patients. Treatment approaches that are beneficial to all CF patients, especially those who do not respond to
current therapies, are urgently needed. Here we propose the development of a generalizable and mutation-
agnostic gene therapy approach with novel compact promoters that enable full-length CFTR delivery. Adeno-
associated viruses (AAV) provide a safe means of therapeutic gene delivery; however, a major obstacle limits
an AAV vector’s utility: its small payload capacity. The large size of the CFTR gene, in addition to a promoter,
terminator, and 2 inverted terminal repeats, presents a significant barrier to AAV packaging. Current strategies
to circumvent the limited capacity employ a small synthetic viral promoter and a truncated CFTR gene; both of
these could have significant drawbacks. Truncated CFTR genes are less active than full-length CFTR, and
hundreds of millions of years of evolutionary conservation further support important functions. Viral promoters
have a propensity to be silenced over time and high transgene expression driven by these promoters can also
be toxic. The fundamental innovation of our approach is the discovery and characterization of hundreds of
compact mammalian promoters that enable packaging and expression of the full-length CFTR gene within a
single AAV vector. In contrast to current approaches that are limited to the properties of a single synthetic viral
promoter, we demonstrate a significant capacity to fine-tune transgene expression levels using endogenous
promoters. In this Phase I we propose to optimize CFTR expression and packaging by characterizing compact
promoters in vitro and in vivo. CFTR coding sequences will be optimized and tested for RNA stability, protein
expression, and functional processing. Finally, the optimized components will be assembled into AAV to validate
proper packaging and CFTR expression using both in vitro and in vivo models. This Phase I proposal enables
parallel track development for a CF therapeutic, and we anticipate that these experiments will provide the basis
for a Phase II to advance a lead therapeutic through IND-enabling studies.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE Cystic fibrosis is a debilitating and ultimately fatal disease that impacts >30,000 individuals in the U.S. that is caused by recessive mutations in the CFTR gene. More than 1,800 distinct disease-causing mutations have been identified in CFTR – and despite tremendous therapeutic advances – many patients do not respond to current medications. We are advancing a mutation-agnostic therapeutic approach that has the potential to benefit all CF patients.